The tRNA pool in C9-ALS/FTD

PROJECT SUMMARY
The C9orf72-mediated ALS (amyotrophic lateral sclerosis) and FTD (frontotemporal dementia) (C9-
ALS/FTD) are two fatal neurodegenerative diseases with no curative treatment. We aim to address a new
mechanism at the core of C9-ALS/FTD to improve the therapeutic potential. While ALS is an adult-onset disease
with progressive degeneration of motor neurons, and while FTD is characterized with progressive decline of the
frontal and temporal lobes of the brain, the two share a common genetic cause – repeat expansion of the
nucleotide sequence G4C2 in the first intron of the C9orf72 gene. Of the proposed causes of C9-ALS/FTD, the
most significant is the synthesis of dipeptide repeat (DPR) proteins from ribosome translation of the expanded
repeats. These DPRs are consistently observed in patient tissues and in various model systems. While the
initiation of DPR synthesis is non-canonical, the elongation of protein synthesis is by the classical ribosome
machinery that translates each codon using a set of tRNA species with the matching anticodon, which is provided
by the cellular tRNA pool. Notably, translation of repeated sequences is highly challenging, requiring repeated
use of the tRNAs for the same codon, where each species must be efficiently charged and post-transcriptionally
modified and matured. This challenge is further intensified in patient cells, where the repeat length can run up to
thousands, raising the question of how the cellular tRNA pool responds to such an unusual demand. This is an
unexplored, but critical, question in C9-ALS/FTD, because the deficiency of quality tRNAs can shift the ribosome
translational reading-frame, leading to frameshifting and synthesis of chimeric DPRs that would alter the disease
pathology. Here we will address this question, based on our extensive expertise in tRNA and in tRNA-associated
ribosome frameshifting. In Aim 1, we will determine changes of the tRNA pool in C9 patient-derived cells relative
to an isogenic control, using our improved tRNA-seq. We will also decipher changes of the ribosome-mediated
global protein synthesis that underlie the disease. We will determine changes both in the iPSC (induced
pluripotent stem cell) state and in the differentiated neuron (iPSN) state, due to their fundamental differences in
regulation of protein synthesis, and due to the potential to produce new insight into the disease during
differentiation. In Aim 2, we will test the hypothesis that the course of DPR synthesis can be induced to undergo
a desired frameshifting to produce less toxic proteins that can reduce the disease pathology. We will test how
changes of the abundance and charging levels of the tRNAs required for DPR synthesis can induce the desired
frameshifting. This work will serve as the foundation for understanding the therapeutic implications of tRNA and
ribosome protein synthesis in the development of C9-ALS/FTD, providing a template that is generalizable to
other aging and neurodegenerative diseases associated with nucleotide repeat expansions.

Public health relevance
PROJECT NARRATIVE Nucleotide repeat expansions in C9-ALS/FTD produce toxic DPR proteins that are synthesized from an unusual initiation codon but are elongated by the classical ribosomal machinery using components of the tRNA pool one codon at a time. Little is known how the composition of the tRNA pool affects the disease outcome, although the repetitive use of a tRNA in high demand can deplete its charging with the cognate amino acid and its maturation with necessary modifications. Here, we will determine the quality of the tRNA pool in patient- derived and in control cells between the iPSC and the differentiated iPSN state to provide new insight that is important for understanding the disease and for exploring new therapeutic potential.